Development of a RIG-I agonist RNA as a cure for chronic Hepatitis B

Project summary:
Despite the availability of a safe and effective vaccine, Hepatitis B virus (HBV) continues to be a major problem,
chronically infecting ~300 million people worldwide and causing more than 500,000 deaths per year. High
numbers of unvaccinated individuals combined with vaccine breakthrough cases continues to allow the virus to
spread throughout the community and cause morbidity and mortality at high rates. Current HBV therapies limit
viral replication, but do not provide a cure for HBV infection. As such, there is an urgent need for innovative
therapeutics to treat HBV infection and provide a lasting cure for infected individuals.
Host-directed therapies (HDTs) offer a promising approach in this regard. Rather than targeting the virus itself,
HDTs target the host to either restrict an essential growth factor or upregulate innate defenses. By targeting the
host to attack the virus, traditional mechanisms of antiviral resistance are circumvented. We are developing a
broad-spectrum antiviral RNA molecule targeting retinoic acid inducible gene-I (RIG-I), a host pattern recognition
receptor (PRR) evolved to recognize viral RNA to trigger innate antiviral immune responses, an approach
validated in preclinical studies to protect mice from multiple RNA and DNA viruses. Our preliminary data show
the RIG-I agonist, RAR, not only prevents HBV replication, but even clears cells of HBV DNA, something
not achieved by any approved HBV treatments. In the proposed studies herein, we will perform critical
formulation optimization to create a final product to be tested for efficacy against HBV infection. We will optimize
parameters of two clinically relevant nanoparticle formulations, including our novel nanoparticle emulsion, which
effectively protects and delivers RNA in vivo. We will optimize formulation parameters and down-select a final
formulation by measuring cytokine release patterns in vivo from the liver, blood, and spleen following innate
immune agonist delivery. The lead formulated RAR complexes will be tested for efficacy against HBV infection
in vitro.
To this point, little progress has been made clinically in developing innate immune agonists as therapeutics. Our
expertise formulating agonists and vaccine platforms (including RNA) for preclinical and clinical trials will allow
us to use a variety of nanoparticle formulations to deliver this RNA RIG-I agonist safely and effectively to
chronically infected individuals. With results from this Phase I project, we will advance our formulated host-
directed RNA molecule into preclinical development and in vivo efficacy studies as part of our Phase II research.

Public health relevance
Project narrative: Hepatitis B virus (HBV) infects ~300 million people worldwide and kills more than 500,000 individuals per year. The aim of this proposal is to develop RAR, a host-directed therapeutic targeting the RIG-I pathway, to become the first treatment capable of curing chronic HBV infections. Using our extensive formulation experience, we will develop PAMP in a clinically relevant formulation that will allow for quick progression to an Investigation New Drug application and human clinical trials to make an impact against this deadly virus.